3-hydroxybutyrate: an unexpected longevity factor in yeast

Abstract
Saccharomyces cerevisiae (budding yeast) has played a key role in identifying and
characterizing multiple longevity factors and healthspan/lifespan interventions such as caloric
restriction (CR), methionine restriction (MetR) and rapamycin (TOR inhibition) but has been
absent from the elucidation of ketone bodies in lifespan regulation. This is likely because the
traditional enzymes for ketogenesis, ketone body catabolism, and the major ketone body
metabolites acetoacetate and b-hydroxybutyrate (BHB), had not been characterized or
significantly detected in this organism. Furthermore, previous metabolomics experiments with
yeast were primarily performed on exponentially growing cells with abundant nutrients (the “fed
state”), a condition that shouldn’t favor ketogenesis if it were to occur. We have unexpectedly
detected BHB as a metabolite in yeast cells as the enter stationary phase, and especially when
grown under CR conditions. This effect is consistent with the ketogenesis that occurs in
mammals during extended fasting or starvation. We also observed strong chronological lifespan
(CLS) extension by BHB supplementation that was equivalent in magnitude to the effect of CR.
Additionally, CR or BHB supplementation correlated with induction of a recently discovered
post-translational protein modification from mammals linked with ketosis, lysine b-
hydroxybutyrylation. Therefore, the goal of this exploratory R21 project is to now characterize
the ketogenesis pathway and develop S. cerevisiae into a novel genetic system for studying the
potential longevity benefits of BHB.

Public health relevance
Narrative. Caloric restriction (CR) is a dietary regimen that extends the mean and maximum life span of eukaryotic organisms ranging from yeast to mammals. CR also has beneficial effects on ‘health span’ in mammalian model systems, often delaying age-associated pathologies. The goal of this research project is to investigate a novel role for the ketone body metabolite b-hydroxybutyrate in promoting CR- dependent chronological lifespan extension in the budding yeast, Saccharomyces cerevisiae. We will also investigate conservation of this new CR paradigm in multicellular aging models, focusing on the nematode worm model, Caenorhabditis elegans.